Pediatric Oncology Branch Clinical Care and Education

The Clinical Director of the Pediatric Oncology Branch oversees the pediatric oncology clinical service at the NIH Clinical Center and has budgetary and supervisory responsibility for the clinical fellows, nurse practitioners, and patient care coordinators. The NCI fellowship training program is a joint training program with Johns Hopkins Medical Institutions. The joint training program is accredited by the Accreditation Council for Graduate Medical Education (ACGME). Together we oversee the mentoring and training of 20 fellows. The POB Clinical Core (CC) played a lead role in the study of atezolizumab in patients with alveolar soft part sarcoma (PI A. Chen), enrolling the majority of pediatric patients who participated in this study which was critical to the FDA approval of atezolizumab for adults and pediatric patients age 2 years and older with alveolar softball part sarcoma. The CC also led the publication of a study of guadecitabine for the treatment of SDH-deficient GIST (2023) and an investigator initiated phase 1 study of ganitumab plus dasatinib for patients with rhabdomyosarcoma.